Mertk-driven regeneration of alveolar bone

ABSTRACT
Partial or complete edentulism results in a loss of oral function and esthetic concerns, which diminishes a
patient’s quality-of-life. Furthermore, regeneration of tissue lost after extraction is not predictable, partially due
to the complexity of the repair/regenerative process. In order to be successful, the oral tissues must navigate
three components of the regenerative process: 1) wound healing, 2) resolution of endogenous inflammation
and 3) promoting growth and differentiation of the native bone tissue. The primary hypothesis of this proposal
is that the receptor tyrosine kinase Mertk regulates early bone formation and this can be used as a therapeutic
target for alveolar bone regeneration. We have previously observed enhanced alveolar bone fill in models of
pharmacological inhibition and genetic knockout of Mertk, and this project will examine the specific
mechanisms through which each modality modulates alveolar bone healing. Specific Aim 1 will determine the
effects of Mertk signaling on resident alveolar bone stem cells that contribute to extraction socket healing.
Specific Aim 2 will examine deletion of Mertk on recruitment and phenotype of immune cells in the extraction
socket underpinning alveolar bone regeneration.

Public health relevance
PROJECT NARRATIVE Edentulism is a debilitating condition that requires alveolar bone regeneration to restore function. Mertk signaling has been implicated in both bone homeostasis and immune cell signaling yet has not been explored as a controlling factor in bone regeneration following injury. This study will establish the connection between Mertk and alveolar bone healing after tooth extraction.